The Vascular Axis in Schizophrenia Brain-Body Aging

Project Summary
People with schizophrenia spectrum disorders have a shorter lifespan and higher morbidity and mortality than
the general population, with cardiovascular conditions on top of the leading causes. Brain imaging research has
revealed accelerated age-related brain changes in patients with schizophrenia spectrum disorders. However,
neuroimaging studies of schizophrenia are typically brain-focused without system-level investigations on the risk
factors. The causes of the exaggerated body and brain aging in schizophrenia is still largely unexplained, making
it difficult to provide more effective screening and management for the devastating medical consequences for
people suffering from schizophrenia. There are likely missing opportunities as vascular contributions to brain,
especially white matter health, are well established in the general population. The goal of the current proposal is
to utilize the standard but state-of-the-art vascular biology measures, combined with cutting-edge brain imaging
that is informative of the underlying mechanisms, to study the potential vascular contributions to the accelerated
age-related brain and cardiovascular diseases in schizophrenia. We will compare various vascular biomarkers
and between vascular and stress factors, to identify the key body-brain paths that may explain the reason that
schizophrenia spectrum disorders are associated with such high age-related medical and brain burden. The
study may provide insights into the timing and mode for more effective screening, prevention and treatment
effort.

Public health relevance
Project Narrative Traditionally viewed as a brain disorder, it has become clear that one of the most devastating outcomes of schizophrenia spectrum disorder is its high rates of medical morbidity and mortality due to mostly age-related medical conditions like cardiovascular diseases. In parallel, accelerated brain aging is also evident. The proposed study is to determine to what extent aberrant vascular biology in schizophrenia may contribute to the earlier onset and more severe brain-body aging burden, which will guide the prevention and early intervention efforts for people suffered from schizophrenia.